Objective Integrated Multimodal Electrophysiological Index for the Quantification of Visceral Pain

Project Summary/Abstract
Visceral pain is the cardinal complaint of patients with Irritable Bowel Syndrome (IBS), an affliction of
approximately 20% of the U.S. population. Drugs to treat visceral pain are limited, with side effects usually
outweighing analgesic benefits. The development of effective treatments for IBS is hampered by the lack of a
reliable biomarker that quantifies the level of visceral pain. Clinical trials of pain-managing drugs rely on patient
reported pain level, a subjective assessment with a strong placebo effect. This has resulted in challenges in
clinical trials for the tested drugs to significantly out-perform the placebo in managing visceral pain. Thus, an
objective integrated multimodal electrophysiological index that quantifies the level of visceral pain is much
needed in developing novel therapies, especially non-drug treatments in managing IBS pain.
The autonomic nervous system (ANS) is the primary pathway in brain-gut communication, and it significantly
overlaps with the neural circuitry for detecting and perceiving pain from the viscera. Our preliminary data have
shown close correlation between ANS activities and subject-reported pain responses to noxious somatic and
visceral stimuli. Compared with healthy subjects, IBS patients show an unchecked predominance of sympathetic
activities and desensitized parasympathetic activities. Also, the amount of abdominal muscle contraction,
measured by electromyogram (EMG), has been established as a metric to differentiate IBS from control
populations in preclinical studies. Thus, the ANS and abdominal muscular activities are promising targets for
developing objective biomarkers for IBS pain.
We aim to leverage our recent technical advances in wearable sensing of electrophysiological signals and
telemetric technology to develop a robust, sensitive, and objective biomarker that quantifies the level of visceral
pain through noninvasive recordings of electrodermal activities (EDA), electrocardiogram (ECG), and EMG. Two
specific aims are proposed. Specific Aim 1 will use machine learning to establish an objective integrated
multimodal electrophysiological (OIME) index based on EDA, ECG, and abdominal EMG for pain quantification
and clustering of IBS patients. Specific Aim 2 will the integrated OIME index as a biomarker to reliably quantify
visceral pain in IBS patients and stratify the IBS population. If successful, we will establish the OIME index from
abdominal belt-worn recordings of EDA, ECG, and EMG as a sensitive and robust biomarker for IBS-related
visceral pain, which will lead to accelerated development of preventive and therapeutic schemes, especially
nonopioid treatment for effective pain management in IBS.

Public health relevance
Project Narrative The goal is to determine and validate an objective integrated multimodal electrophysiological index to assess the level of visceral pain in patients with irritable bowel syndrome (IBS). We will establish this objective biomarker through non-invasive surface recordings of the autonomic neural activities and building a mathematical prediction model via machine learning algorithms. This biomarker will lead to accelerated development of preventive and therapeutic schemes, especially non-opioid treatments for effective pain management in IBS.